Establishing the feasibility of measuring bereavement-related stress in a naturalistic setting

PROJECT SUMMARY/ABSTRACT
Spousal bereavement is associated with increased mortality, cardiovascular disease (CVD) morbidity, and
diminished quality of life. While most individuals are resilient and eventually adjust to the loss, there is great
variability in the type and severity of stressors that individuals experience in the first months following the loss.
Grief self-report scales inquire about these stressors, but usually ask individuals to rate how often they
experienced symptoms over the past 1-2 weeks. Although bereavement is a dynamic process, limited data is
available on the day-to-day fluctuations in bereavement-related stress and the affective and physiological
changes that follow. Affective stress reactivity refers to the changes in affect in response to a stressor while
autonomic stress reactivity refers to changes in heart rate (HR) and heart rate variability (HRV). Both affective
and autonomic stress reactivity have been associated with adverse mental and physical health outcomes in the
general population. Emerging data also show that bereaved spouses have lower levels of HRV, indicative of a
dysregulated stress response, when compared to married controls. Therefore, individual differences in stress
reactivity among bereaved spouses may be linked to the detrimental health outcomes observed in this
population. Our understanding of stress reactivity, however, comes from studies conducted in highly controlled
laboratory settings and laboratory stressors are unlikely to capture the variety and severity of stressors
experienced in bereavement. Thus, research examining stress reactivity among bereaved spouses in
naturalistic settings is critically needed. The objective of the current study is to address this gap in the literature
by establishing the feasibility of using stress reactivity to better capture experiences of daily stressors in
spousal bereavement. We will use a novel approach that combines ecological momentary assessment with
HRV measured by continuous electrocardiography (ECG) monitoring to generate personalized (person-level)
measures of stress reactivity. Data will be used to develop two measures of stress reactivity: affective reactivity
(changes in negative affect in response to a stressor) and autonomic reactivity (changes in heart rate and heart
rate variability in response to a stressor). The pilot and feasibility data generated by this study will support
future studies examining the role of stress reactivity as a mechanism linking bereavement, CVD, and other
health outcomes.

Public health relevance
PROJECT NARRATIVE The death of a spouse is a highly stressful life event that is associated with increased mortality and worsening mental and physical health. Although bereavement is a dynamic process, limited data is available on the day- to-day fluctuations in bereavement-related stress and the affective and physiological changes that follow. This study will use ecological momentary assessment and continuous electrocardiography to measure affective and autonomic stress reactivity among bereaved spouses in a naturalistic setting and has the potential of improving our overall understanding of bereavement-related stress and its link to worsening health.